Blunted mechanosensation of the heart and gut as a mediator of pathogenesis conferred by chronic social subjugation

Project Summary
In the coming decades, cardiometabolic and affective disorders will become an epidemic in the U.S. These
disorders disproportionately afflict racial and ethnic minorities. While wealth and geography contribute to health
disparities, emerging evidence indicates that rank within a social hierarchy is a potent predictor of pathogenesis.
Consistent with this notion, we’ve determined that mice rendered subordinate in the chronic social defeat stress
(CSDS) paradigm become hypertensive, exhibit marked weight gain and increased anxiety-like behavior. Insight
on causal mechanisms comes from our prior studies on cardiometabolic interoception. We discovered that
neurons within the nodose ganglia that express oxytocin receptors (hereafter referred to as NDGOxtr) serve as
mechanoreceptors that relay stretch exerted on the heart and gut to brain circuits orchestrating cardiovascular
and gastrointestinal function. Fascinatingly, chemogenetic activation of NDGOxtr imitates the sensation of
vascular and gastrointestinal stretch, thereby producing compensatory reductions in blood pressure and food
intake. Impaired interoception is implicated in the etiology of cardiometabolic and affective disorders and our
preliminary studies suggest that CSDS blunts mechanosensation of the heart and gut. That is, subordinate mice
have impaired baroreflex sensitivity, consume large meals, and neurons within the nodose ganglia (NDG) have
reduced expression of Piezo2 mRNA (i.e., molecular mechanoreceptor). These observations have led to the
overall hypothesis that blunted mechanosensation of the heart and gut by NDGOxtr contributes to the
development of cardiometabolic and affective disorders that accompany social adversity. We propose
the following three aims to test this hypothesis. Aim 1 uses intravital imaging to investigate the impact of CSDS
on NDGOxtr activity in response to mechanical stretch of the vasculature and gut. Aim 2 uses a genetically
engineered mouse model to determine whether deleting Piezo2 from NDGOxtr recapitulates and/or exacerbates
the effects of CSDS. Aim 3 uses chronic chemogenetics to determine whether stimulating NDGOxtr during CSDS
restores cardiometabolic mechanosensation and alleviates the deleterious effects of CSDS. Collectively, our
experiments will reveal, at a detailed and mechanistic level, whether 1.) chronic social stress impairs
mechanosensation of the heart and gut, 2.) downregulation of Piezo2 within NDGOxtr contributes to the
hypertension, hyperphagia, and anxiety-like behavior that comes with chronic social stress, 3.) restoring
mechanosensation of the heart and gut by activating specific vagal sensory afferents is a viable therapeutic
strategy. By elucidating the mechanisms by which social stress disrupts body-to-brain communication this
research has the potential to identify novel therapeutic targets for improving health outcomes in populations
experiencing social adversity.

Public health relevance
Project Narrative This proposal investigates how chronic social stress disrupts communication between the body and brain to cause high blood pressure, weight gain, and mental health disorders. We propose that the mental stress that comes with low social status impairs how the brain senses the heart and the gut. Completion of this work may identify new therapeutic strategies to restore body-to-brain communication to improve health in disadvantaged populations.